Data Management and Statistics Core

PROJECT SUMMARY – DATA MANAGEMENT AND STATISTICS CORE
The Data Management and Statistics Core (DMSC), which includes a Data Management Program (DMP) and a
Statistics Program (SP), will provide comprehensive, integrated, and continually updated data management for
the acquisition, organization, use, and sharing of data from research participants in the New Mexico (NM) ADRC.
The DSMC will ensure timely and fully compliant transmission of ADRC UDS4 data, Brain Donor information,
brain images, and other data to NACC and SCAN, and work with NCRAD to provide coordinated blood sample
and DNA sample sharing reports. The DMSC, comprised of a Data Management Program (DMP) and a Statistics
Program (SP) will be fully integrated with NM ADRC leaders, Cores, REC, and other ADRCs. The DMP will
ensure: 1) accuracy, completeness and timely submission of fully compliant data and images from the ADRC
and its Affiliated Programs; 2) user-friendly access to, and appropriate use of, anonymized data and available
biological samples for researchers inside and outside of NM; 3) development and provision of relevant reports
for the ADRC’s Cores and REC including monitoring and optimizing their performance; and 4) act as a catalyst
for new collaborations. The SP has assembled a highly coordinated, close-working expert team to address the
analytical, statistical, and career development needs of researchers, trainees, and collaborators from a wide
range of disciplines, ADRC organizations, and other programs. The SP will: 1) contribute to research design,
statistical methods, size, and statistical power of their studies, analyze data, interpret findings, contribute to the
preparation of grants, abstracts, and manuscripts, and develop their analytical skills; 2) provide information and
assistance with available ADRC and Affiliated Program data and samples and support the productive use of data
and/or samples from National Alzheimer’s Coordinating Center (NACC), National Centralized Repository for
Alzheimer’s Disease and Related Dementias (NCRAD), and other research programs and publicly available
data. The SP will continue to develop, implement, test and support the proper use of new computational,
mathematical, statistical, big-data, machine-learning, data-mining, data-harmonization, and image-analysis
tools, and new approaches to the use of clinical, imaging, and fluid-based biomarker data. The DMSC will
integrate seamlessly within the NM ADRC to advance the overarching theme of understanding vascular and
inflammatory contributions to Alzheimer's and cerebrovascular diseases in underrepresented groups in New
Mexico.